Reducing Burnout among VA PCPs Using Evidence-Based Quality Improvement

Background: Burnout, a long-term psychological response to chronic workplace stress, is highly prevalent
among providers and staff in VA primary care. Healthcare worker (HCW) burnout is not only detrimental to
affected individuals, but also to the organizations that they work in. High rates of HCW burnout are linked to
increased medical errors, worse quality of care, and worse patient experience. Burned out HCWs also work
fewer hours and are more likely to leave their organization. Organizational interventions to reduce burnout are
more effective than individual interventions, but no single organizational intervention is applicable to all
settings. We propose to use evidence-based quality improvement (EBQI) to utilize collaborative leadership and
PACT teamlet input to develop and pilot test a burnout reduction intervention, informed by evidence and
facilitated by experts, that is tailored to the specific needs of participating primary care clinics. Findings from
this work will inform strategies for implementing burnout interventions in other VA facilities, adapted to local
organizational contexts. Significance/Impact: In VA, 31-55% of providers, nurses, clinical associates, and
administrative associates in patient-aligned care team (PACT) teamlets consistently report burnout. Strong
primary care models are essential to the VA’s integrated delivery system. High burnout, and subsequent
turnover, could erode that strength by decreasing primary care staffing, team function and PACT fidelity,
thereby impairing Veteran access and shifting more care to the community. Addressing burnout in primary
care before it leads to larger downstream effects is essential to preserving Veteran health and the integrity of
the VA healthcare system. In addition, addressing burnout in primary care meets the HSR&D and ORD
research priorities of primary care practice and complex chronic disease management, and of increasing
substantial real-world impact of VA research. Innovation: EBQI is an effective and well-evaluated strategy
that aided in the implementation of PACT, Women’s Health PACT, depression collaborative care, and smoking
cessation guidelines. The strategy also reduced provider and staff burnout during PACT implementation, but
has never been used in tandem with burnout interventions to optimize impacts. This CDA is the first endeavor
to combine EBQI as an implementation strategy with evidence-based burnout interventions, adapted for local
organizational contexts. Through EBQI, a multi-level, collaborative approach that empowers frontline HCWs,
we may increase the feasibility and impact of burnout reduction interventions. Specific Aims: In this CDA, I
aim to: Aim 1: Understand facility- and clinic-level drivers of burnout in VA primary care; Aim 2: Develop
burnout reduction interventions using an EBQI approach; and Aim 3: Evaluate feasibility, acceptability, and
effectiveness of the pilot EBQI-facilitated burnout reduction interventions. Methodology: For Aim 1, I will
measure burnout and identify burnout drivers using surveys and interviews, which will serve as the foundation
for stakeholder-engaged priority setting processes using EBQI to design locally-tailored evidence-based
burnout reduction interventions. Aim 2 will involve integrating the key drivers of burnout and intervention
activities identified in Aim 1, and developing EBQI-facilitated burnout interventions (using stakeholder panels,
quality improvement training, formative feedback, and practice facilitation). Aim 3 will entail evaluation of the
feasibility, acceptability, and effectiveness of the EBQI-facilitated burnout interventions in a pilot stepped
wedge design among five VA medical centers and community-based outpatient clinics in VISN 22. During Aim
3, I will also use interviews to identify intervention barriers and facilitators. Next Steps / Implementation:
In Years 3 and 5 of this CDA, respectively, I will prepare and submit IIRs to conduct a national organizational
survey to identify and study the impact of burnout drivers in VA primary care, and a larger multi-site cluster
randomized controlled trial to fully evaluate the effectiveness and impacts of EBQI-facilitated burnout
reduction. Findings will also be shared with national and local stakeholders to inform future implementation.

Public health relevance
Burnout is highly prevalent among VA primary care providers and staff, impairing productivity and retention, as well as safety, quality, and patient experience. In this CDA, I will use mixed methods to assess burnout and its drivers, integrate systematic review evidence with knowledge of burnout drivers to develop a menu of burnout reduction interventions using an evidence-based quality improvement (EBQI) approach, and then evaluate the feasibility, acceptability and effectiveness of a pilot EBQI-facilitated burnout reduction intervention in a modified stepped wedge design in VISN 22. This CDA will also provide the mentorship and training in primary care delivery models, implementation science, organizational research and qualitative methods necessary for me to become an implementation scientist with nationally recognized expertise in employee burnout, retention, and well-being, capable of developing, implementing, and spreading effective interventions to optimize workforce stability and care delivery in VA primary care.